Core E: Biostatistical and Data Management Core

ABSTRACT Building on 25 years of close collaboration between the Core Leader (Professor Maislin) and the Program Project Director (Dr. Allan Pack), and as long with many of the Program's investigators, collaborators, and consultants, the primary responsibilities of Core E will be to guarantee the application of good statistical and scientific practice in the conduct of every research protocol; to collaborate with investigators in the design and development of research protocols; to insure the implementation of the statistical analysis plans developed for the Projects; to develop new approaches to analysis and to adapt and adopt new approaches appearing in the literature that are relevant to the Specific Aims; and to ensure the fair, accurate, and unbiased publication of research findings. This Core will also manage the capture and storage of clinical data through the use of the REDCap system.

Public health relevance
LAY NARRATIVE The Biostatistics and Data Management Core has been supporting research at the Center for Sleep and Circadian Neurobiology under the leadership of Greg Maislin, Adjunct Professor of Statistics in Medicine since 1990. Members of the Core work collaboratively with faculty and investigators to ensure that proper and valid statistical methods are used in the analysis of data. The Core adapts existing methods or develops new methods as needed to address scientific challenges as they arise. Finally, the Core supports an integrated data management system that is secure, compliant with privacy regulations, and allows data to be captured, organized, and available for statistical analysis.